Characterization of P. aeruginosa sRNAs that are highly expressed in human chronic infections

Project Summary
Pseudomonas aeruginosa (PA) is an opportunistic pathogen responsible for both acute and chronic infections.
These infections, particularly in the case of chronic polymicrobial wounds, are often challenging to eliminate. Our
current understanding of the mechanistic aspects of PA polymicrobial wound infection largely stems from
experiments conducted in vitro and in animal models. However, the extent to which these models accurately
replicate PA functions crucial for human chronic infection remains unclear. In this proposal, the function of two
genes (sicX and PA3237) that encode small RNAs highly expressed in human polymicrobial wounds will be
elucidated. The overarching hypothesis is that sicX and PA3237 encode sRNAs that post-transcriptionally
modulate functions critical for polymicrobial wound infection and antimicrobial tolerance. We will test this
hypothesis by: (i) defining the molecular mechanism by which SicX controls its target genes; (ii) elucidating the
mechanism(s) controlling SicX-mediated dissemination in the murine surgical wound model; and (iii) identifying
the targets of the PA3237 sRNA, focusing on its role in promoting survival to cationic peptide antimicrobials and
oxidative stress. This study aims to fill a critical void in our understanding of PA physiology during polymicrobial
wound infection, potentially uncovering new diagnostic and therapeutic targets for the future.

Public health relevance
Project Narrative This research aims to elucidate the mechanism(s) by which two small RNAs in the bacterial pathogen Pseudomonas aeruginosa mediate infection severity and antimicrobial tolerance in polymicrobial wound infections. The ultimate objective is to uncover insights that will pave the way for the development of effective therapeutic strategies to combat these complex infections.